MAGNET: MAKING GENOMICS ACCESSIBLE FOR NEWBORNS IN TEXAS

ABSTRACT
The great advances made in genomic medicine that impact diagnoses and care of newborn babies in large
academic centers in Texas are generally not available at most level III and level IV NICUs across the state. Major
populations in predominantly Hispanic regions such as El Paso and the Rio Grande Valley lack local access to
medical genetic expertise, capacity for genomic testing, and frontline practitioners with the knowledge to leverage
personal genomic data to improve care. Residents in these remote areas must travel over 300 miles to reach
the nearest in-state geneticist. Only twenty years ago, less than three percent of genetic conditions in newborns
could be molecularly diagnosed. Today, with routine genomic tests at academic medical centers, over one third
of these cases are diagnosed. Unfortunately, many babies born outside of these privileged communities lack
access to genetic evaluation and testing, remain undiagnosed, and are unable to benefit from early personalized
medical treatment. Here, we propose to dramatically improve the diagnosis of the sickest newborns in hospitals
across underserved regions of Texas using a new generation of clinical assays (whole genome and RNA
sequencing), leveraging a lower cost sequencing technology and Consultagene, our established remote
consultation service and platform. This combined approach (MAGNET) will improve access to care, reduce
health disparities, increase the scale and quality of the genomic data generated at reduced cost for the ethnic
minority newborns, and advance personalized care. Moreover, we propose to make these diagnostic strategies
available through a telehealth-based approach expanding access to medical genetics expertise while improving
patient and provider engagement and education, at both academic and community neonatal intensive care units
across Texas. This strategy will greatly democratize genome technology, enhancing access in geographically
remote, poor, underserved, and minority communities, and reaching a much larger proportion of hospitalized
newborns. As such, our work will serve as a model for providing genetic diagnoses in an equitable fashion amid
diverse communities in NICUs across the United States.

Public health relevance
NARRATIVE There is significant health care disparity in access to genomic medicine among sick newborns in broad areas of Texas. Our proposed work will provide evidence of the impact of a virtual platform for telegenetic consultation service with low-cost genomic sequencing to reduce this disparity, as well as determine best practices for implementation.